Using a Pragmatic Randomized Rollout Trial to Evaluate Implementation Strategies to Promote Smoking Treatment and Cancer Prevention for Salvation Army Clients

ABSTRACT / PROJECT SUMMARY
The prevalence of combustible cigarette tobacco use remains high among socioeconomically disadvantaged
Americans despite declines in the broader population. Socioeconomic inequities in tobacco use rates and
tobacco cessation success have grown over recent decades. Disadvantaged adults who use tobacco are
therefore a high-priority population, but we have made too little progress in engaging this population in
evidence-based tobacco cessation treatment. Community agencies that provide support services to
disadvantaged individuals have the potential to reach people who use tobacco and engage them in high-quality
cessation treatment to prevent cancer. The Salvation Army is a community agency with national and
international reach and a commitment to discouraging tobacco use and promoting the health and wellbeing of
the diverse communities they serve. The Salvation Army will partner in the proposed project to refine and
evaluate implementation strategies designed to help their staff connect their clients with free evidence-based
tobacco treatment from the Wisconsin Tobacco Quit Line. Salvation Army social service leaders, staff, and
clients will help to refine and adapt quitline referral implementation strategies with promising preliminary data to
enhance their fit and sustainability in the usual context of Salvation Army services. Pragmatic research
methods will be used to evaluate two promising implementation strategies designed to promote quitline
referrals: 1) a low-intensity, sustained collaborative approach to implementation support for Salvation Army
staff (vs. a usual care approach offering initial training with minimal technical support), and 2) modest,
immediate incentives for clients to connect with the quitline (vs. no incentive). Both the collaborative sustained
implementation support for staff and client incentives will be refined in the 2-year UG3 phase, along with
pragmatic study measures and procedures. In the UH3 phase, the target implementation strategies refined in
the pilot phase will then be evaluated in a pragmatic randomized rollout trial in which 8 sites are randomized to
sustained collaborative implementation support for staff and 8 sites are randomized to usual implementation
training for staff, and all 16 sites will start without client incentives for immediate quitline connections, and will
then introduce incentives at randomly assigned timepoints, as in a stepped-wedge design. Inclusion criteria for
sites, staff, and clients will be minimal to enhance external validity, and data on the primary outcome (whether
or not a referral occurred) will be gathered from Salvation Army service records and quitline records in the
course of usual care. This will be supplemented by mixed method assessments conducted by researchers that
will not affect the context of intervention implementation. This pragmatic program of research has the potential
to identify staff- and client-focused strategies that can enhance Salvation Army efforts to support tobacco
cessation among their clients. Leaders at the Salvation Army are committed to helping their clients quit
tobacco, and to applying the lessons learned in the proposed project more broadly in the region and nation.

Public health relevance
NARRATIVE Community agencies that provide support to socioeconomically disadvantaged communities have tremendous potential to help their clients who use tobacco get help in quitting tobacco. Pragmatic research can help identify strategies community agencies can use to connect their clients with evidence-based tobacco use treatments. This project will first refine and pilot test promising strategies designed to engage social service workers and clients in tobacco quitline referral, and then will evaluate these strategies in a randomized controlled trial.